J. NRSA Training Core

The NRSA Training Core (TL1 Core) is a critical educational component of the Georgia Clinical & Translational
Science Alliance (Georgia CTSA) which represents a collaboration between Emory University, Morehouse
School of Medicine (MSM), Georgia Institute of Technology (Georgia Tech) and the University of Georgia
(UGA). The TL1 Core is closely linked with the Institutional Career Development Core (KL2 Core) and
governed by a joint KL2-TL1 Research Education Executive Committee. The TL1 Core provides didactic and
mentored clinical and translational research (CTR) training to Georgia CTSA-supported predoctoral and
postdoctoral trainees with the overarching goal of equipping them with the scientific skills, tools and methods to
enhance the translation of their discoveries to improve human health. The TL1 Core in collaboration with the
KL2 Core support two successful CTR didactic and mentored training programs: the Master of Science in
Clinical Research (MSCR) degree program, and the Certificate Program in Translational Research (CPTR).
Since the formation of our CTSA in 2007, there has been 116 long-term TL1 trainees, including the 14
incoming TL1 trainees in July 2021; 65% are women, 48% are non-White and 21% are underrepresented
minorities (URM). TL1 trainees remain highly engaged in CTR, (94% of 103 former TL1 trainees since 2007
have remain engaged in CTR careers, including 84 in academia, 7 in industry, 5 in the federal government
[CDC, NIH]), and 1 in non-university CTR. Since the establishment of Georgia CTSA in 2017 as a large CTSA,
we have had a major expansion of the TL1 Core with the addition of TL1 postdoctoral trainees to a program
that that had previously supported predoctoral trainees. Since 2017, we have had 66 TL1-appointed trainees
and an additional 63 pre- and postdoctoral trainees from the partner institutions supported by T32 grants or
through institutional support who have received CTR training in the Georgia CTSA-supported MSCR or CPTR
programs. In the coming cycle, we will continue to innovate the TL1 Core to enhance the diversity of our
training pipeline, expand the pool of URM trainees, and support an enhanced CTR training curriculum that
offers all trainees, regardless of their background, the skill sets needed to develop a successful career in CTR
that can effectively address health equity. The TL1 Core will support 18 TL1 slots per year (12 funded by NIH
and 6 institutionally supported slots, 3 of which are dedicated to URM trainees). TL1 specific aims include:
1) To provide innovative personalized training pathways by supporting successful didactic and mentored CTR
training programs for a diverse cadre of pre- and postdoctoral TL1 and other trainees at the four partner
institutions; 2) To enhance equity and promote inclusion through the recruitment of a diverse group of trainees
and enhance mentorship and the TL1 mentor training program; and 3) To integrate research methods in
behavioral and social sciences and dissemination & implementation science into our training programs and
enhance opportunities for community engagement to help address health equity among diverse populations.

Public health relevance
The TL1 Core is a critical component of the Georgia Clinical & Translational Science Alliance (Georgia CTSA) and designed to respond to the needs of training a new and diverse generation of clinical and translational research (CTR) investigators focused on improving the health of diverse communities. The TL1 Core provides didactic and mentored CTR training to a diverse group of predoctoral and postdoctoral trainees at the four partner Georgia CTSA institutions (Emory University, Georgia Institute of Technology, Morehouse School of Medicine, and University of Georgia). The TL1 Core (in collaboration with the KL2 Core) also provides CTR training infrastructure at the Georgia CTSA institutions through support of a Master of Science in Clinical Research (MSCR) program and a Certificate Program in Translational Research (CPTR).